Impact of Medicare and Medicaid Financial Policies on Post-acute and Long-term Care for Persons Living with Dementia

Project Summary: The current proposal, developed in response to RFA-AG-24-031 (Consortium for Economic Research on AD/ADRD Prevention, Treatment, and Care) will leverage the last 15 years of Medicare claims and clinical assessment data and econometric methods to advance our understanding of how post-acute and long-term care use and health outcomes for persons living with ADRD are impacted by the changing landscape of health care financing. The 6.7 million Americans living with ADRD are the most frequent users of long-term care services. Unfortunately, the current long-term care system is characterized by substantial barriers to access, variation in service quality, and potentially inefficient resource allocation across community-based and institutional care settings. In nursing homes, the predominant institutional long-term care setting, persons with ADRD often experience adverse care outcomes such as falls, avoidable hospitalization, and excessive psychotropic medication use. Although home- and community-based care services (HCBS) are an increasingly used alternative to institutional long-term care, the efficacy of HCBS for individuals with ADRD is unclear and many barriers to accessing HCBS remain poorly understood. A signature feature of the long-term care system is its reliance on post-acute care and more broadly, the involvement of multiple payers. However, our understanding of recent significant changes to the Medicare and Medicaid financing landscape on post-acute and long-term care utilization and outcomes is limited. Aim 1 of this proposal focuses on the changing use of nursing home and home health services among persons with ADRD in the context of states’ expansion of HCBS funding and constraints on provider supply from certificate of need laws. Aim 2 focuses on the evolution of MA in long-term nursing home care, a largely ignored area despite the explosive growth of the MA program. This Aim also includes an evaluation of a potential promise of MA in long-term care: the institutional special needs plans model. Aim 3 focuses on changes to a post-acute care revenue stream on the quality of post-acute and long-term nursing home care. Post-acute care spending has been a consistent target for saving Medicare dollars despite the importance of these funds for nursing home quality. Our study takes advantage of federal policy that reduced cost-sharing revenues for nursing homes, but in application affected nursing homes differently based on whether their state Medicaid programs had ‘lesser-of’ payment rules. Completion of this entire project will be a significant contribution given the projected increase in the number of people living with ADRD whose health outcomes may be sensitive to these financing and supply-side policies. Each Aim also includes analyses that explore patterns of utilization and outcomes across different population subgroups, including those with varied socioeconomic characteristics or Medicaid eligibility. The findings may inform future policy efforts to improve the alignment of funding and service delivery in post-acute and long-term care, ultimately promoting appropriate care access and outcomes for the ADRD population.

Public health relevance
The proposed study aligns closely with several strategies under Goal 2 of the National Plan to Address Alzheimer’s Disease. It addresses the role of healthcare financing and policies in shaping health outcomes and service utilization for individuals living with ADRD—topics that remain among the highest-priority areas for NIH. Knowledge gained from this work can be used to help “optimize care quality and efficiency” and “maintains the dignity, safety, and rights” for persons with ADRD.